The microbiome associated with oral Leukoplakia: A multi-omics mechanistic study

Project Summary
There is increasing interest in the role of the microbiome in the development and/or progression of various
cancers including oral squamous cell carcinoma (OSCC). Research has shown that OSCC is associated with a
distinct microbiome. However, OSCC in itself represents a late stage in a disease process in which the observed
microbial changes are as likely to be passenger or, at best, late driving events. To better understand the role of
the microbiome in OSCC and identify microbial biomarkers for early detection and prevention, it is crucial to
assess the microbiome in early stages of the disease, e.g. oral potentially malignant disorders (OPMDs). Oral
leukoplakia (OL; the focus of this study) is the most common OPMD. Little is known about the microbiome
associated with OPMDs, its role in their progression, or its potential as non-invasive diagnostic biomarker to
complement oral epithelial dysplasia grading, currently the best available indicator. Our long-term goal is to
identify diagnostic/prognostic microbial biomarkers of OPMDs and determine the effect of the microbiome on
oral carcinogenesis by conducting a large-scale, international consortium study in two phases: a case-control
study (this application) to comprehensively study the dysbiotic microbiome associated with OL/dysplasia in a
North American population; followed by a longitudinal study (future application) that will involve following up the
same and additional cohorts of OPMDs to identify/validate microbiome biomarkers of malignant transformation
(MT). Our hypothesis is that shifts in microbiome composition and function associated with OL represent early
driver events that correlate with the severity of dysplasia and contribute to the progression of oral cancer. In
addition, we also hypothesize that oncogenic strains of oral microorganisms could be driving these disorders.
To address these hypotheses, we propose 3 specific aims: 1) Characterize the composition of the multi-kingdom
microbiome associated with OL and the different grades of dysplasia; 2) Define both microbial and host
transcriptomes in OL and potential interactions between these two segments of the metatranscriptome. 3)
Assess in vitro the oncogenic properties of bacterial and fungal strains isolated from OL. The study will be
conducted by a team of international experts and will enroll 210 OL patients, 105 OSCC patients, and 420 healthy
control subjects (735 subjects in total) to be recruited in two study centers. One-thousand and five hundred saliva
and swab samples will be analyzed using shotgun metagenomic and metatranscriptome analysis. Furthermore,
36 bacterial/fungal strains previous isolated from OL patients with different grades of dysplasia will be screened
for their effect on proliferation, invasion, epithelial-mesenchymal transition and cytokine and matrix
metalloproteinases production by normal and dysplastic epithelial cells in vitro. The study will establish the role
of the microbiome in the early stages of oral carcinogenesis, and identify microbial biomarkers of OL and
dysplasia, which in a subsequent study can be validated as biomarkers of MT.

Public health relevance
Project Narrative Oral cancer, which is a deadly and a debilitating disease, is usually preceded by a visible precancerous lesion called oral leukoplakia (OL). The discovery of markers that can distinguish OLs that are most likely to progress to cancer from those that are unlikely to be harmful, has the potential to improve patient outcomes and to reduce costs to health care systems. This study will investigate the composition and function of microbial communities (microbiomes) in saliva and swab samples from OL cases to be recruited in the USA and Canada, and explore their potential as biomarkers for detection of high risk lesions.